A Multicenter Collaborative Clinical Study to Identify Novel Causes of Severe Pediatric Growth Disorders

Normal growth is a hallmark of childhood health. Poor growth is one of the most common reasons for referral
to a pediatric endocrinologist. Despite extensive evaluation, the vast majority of children with growth disorders
do not receive an etiological diagnosis. A subset of these children with severe growth disorders likely have
undiagnosed genetic causes of their poor growth. Without an understanding of the patient's underlying disease
etiology, physicians are often at a loss as to how to counsel and treat these patients.
Our work focuses on using bioinformatics searches of the electronic medical records to define clinical
subgroups of growth disorders and then carefully clinically characterizing those patients in combination with
genomic studies to identify novel genetic etiologies for these subgroups. We then perform follow up laboratory
work as well as further physiological studies to gain a better understanding of the pathophysiological
consequences of these genetic variants. Our ultimate goal is to provide targeted care for growth disorders
based on the individual patient's specific pathophysiology.
The current proposal focuses on three specific subgroups of patients: 1. Patients with growth hormone
resistance, 2. Patients with resistance to insulin-like growth factor 1 (IGF-I), and 3. Patients with severe short
stature inherited from a single parent. Patients meeting criteria for each of these subgroups are quite rare. To
address this issue, we have formed the first multicenter collaborative group in the United States focused on
studying growth disorders. This group consists of investigators at three of the leading pediatric networks in
America: Cincinnati Children's Hospital Medical Center, Boston Children's Hospital, and The Children's
Hospital of Philadelphia. Targeted bioinformatics searches of the electronic medical record systems will be
performed at each of these hospitals to identify eligible patients. Patients will then be recruited for careful
clinical characterization as well as acquisition of DNA samples. Whole exome sequencing and chromosomal
microarrays will be performed to identify the genetic etiologies followed by translational laboratory studies to
investigate the biological consequences of novel genetic variants. Pilot studies of targeted interventions based
on etiologies will be performed.

Public health relevance
The vast majority of children with severe growth disorders never receive an etiological diagnosis, and thus physicians are at a loss as to how to counsel and treat these patients. This multicenter collaborative study seeks to use bioinformatics searches of the medical records at three large pediatric institutions to define clinical subgroups of children with growth disorders. These patients will then undergo detailed genetic and physiological studies to identify novel etiologies for their severe growth disorders, thereby gaining insight into the biology of growth with the ultimate goal of providing targeted therapies for children with severe growth disorders.